THE STRUCTURE AND FUNCTION OF BIOLOGICALLY ACTIVE MOLECULES

The structural design, chemical synthesis, and modification of molecules important to reproductive and developmental biology are the focus of this study. A. Broad spectrum anti-microbial substances (Magainins) isolated from skin of Xenopus laevis have been purifed to homogeneity by reverse-phase high performance liquid chromatography. Amino acid sequence analyses by Edman degration and carboxypeptidase Y digestion have revealed two sequences, magainin I and II which differ in two substitutions shown in parentheses for II: G-I-G-K- F-L-H-S-A-G(K)K-F-G-K-A-F-V-G-E-I-M-K(N)-S. These sequences have been confirmed by both chemical synthesis and cDNA sequence analyses. Circular dichroism studies indicate that margainin peptides do not form alpha-helices in aqueous buffers. However, magainin I and II display 24% and 26% alpha-helical conformation in lipophilic solution (49% trifluoroethanol), respectively. These results indicate that the peptides are amphiphilic in structure which suggests that the lytic action of magainins may stem from a highly selective penetration into bilayers of microorganisms. B. A peptide comprising the last 37 residues of human chorionic gonadotropin beta-subunit has been synthesized and purified. Through the thiol function of Cys2, the peptide was coupled to a m-maleimidobenzoylated epsilon-amino groups of Keyhole Limpet hemocyanin. This two-step conjugation approach yields a conjugate which contains 2:1 peptide to protein ratio (by weight) and permits the maximal exposure of antigenic sites.